Open-Source Software Tools for Rapid Radiofrequency Coil Modeling and Simulation in MRI

Project Summary
The aim of this project is to develop a novel, rapid, and memory efﬁcient open-source software for
radiofrequency (RF) coil modeling in magnetic resonance imaging (MRI). Ultra-high ﬁeld (UHF) scanners
(> 3T) can reveal remarkable anatomical details to diagnose diseases much earlier than high ﬁeld scanners.
Nevertheless, the operating wavelength at UHF is shorter than the dimensions of the body, therefore constructive
and destructive interference patterns of the coil-generated RF ﬁelds can occur in the torso and head. This can
lead to local RF energy deposition hotspots, which is a patient’s safety concern, and signal dropouts that can
deteriorate the diagnostic quality of the MRI. To address this, electromagnetic (EM) simulations are used for
the careful design and evaluation of RF coils arrays before prototyping. Commercial software can perform such
simulations but are restricted by expensive licenses and can be prohibitively slow for the optimization of complex
setups, for example, two months of simulation time for a 64-channel receive coil at 7T.
A novel, highly accurate and memory-efﬁcient EM simulation tool for MRI modeling is proposed in this project.
Aim 1 will focus on the development of a domain decomposition method for modeling the EM interactions
between RF coils and biological tissue, using wire, surface, and volume integral equation methods. Tensor
decompositions will be used to assemble low-memory formats of these interactions for faster simulations, which
can be run on a GPU for hundred times speedup compared to commercial packages. Aim 2 will focus on devel-
oping an RF circuit simulator for coil tuning, matching, and decoupling using particle swarm optimization.
These methods will form a co-simulator for comprehensive RF coil modeling in MRI. In Aim 3 we will focus on
the validation of the novel simulation software, comparing its accuracy, memory, and speed to commercial pack-
ages and experimentally measured ﬁelds at 7T. The software will be used to design, optimize, and construct a
novel 7T coil for prostate imaging.
This project will utilize, for the ﬁrst time, tensor decompositions to create a powerful and innovative EM mod-
eling software tool for MRI. The software will be compatible with any MRI frequency and anatomy without the
need for expensive licenses. This “Pathway to Independence” award proposal also includes a mentored career
development plan to help the candidate, Dr. Ilias Giannakopoulos, becoming an independent investigator. His
primary mentor, Dr. Riccardo Lattanzi, and co-mentors Dr. Daniel Sodickson and Dr. Ryan Brown, are leading
experts in the ﬁeld of EM interactions with biological tissue and coil design. The diversiﬁed mentoring plan and
the complementary background of these mentors will provide valuable exposure to coil design and prototyping,
UHF MRI, and interdisciplinary collaborations to help the candidate transition to an independent investigator posi-
tion. Ultimately, Dr. Giannakopoulos aims for a successful career as a faculty member in Radiology or Biomedical
Engineering, researching hardware and software tools to advance clinical biomedical imaging.

Public health relevance
Project Narrative The goal of this project is to develop an open-source electromagnetic simulation suite for radiofrequency coil design and modeling in magnetic resonance imaging (MRI). Novel computational electromagnetics methods will be developed and combined with optimization routines and tensor decompositions to allow efﬁcient simula- tions of realistic MRI setups for brain and body imaging at any operating frequency. The proposed suite will be used for the rational design, optimization, assessment, and construction of a novel coil array for prostate imaging at 7T MRI.